The LiaFSR system and antimicrobial peptide resistance in enterococci

ABSTRACT
The emergence of antibiotic-resistant bacteria is one of the greatest threats to human health in the 21st
century. In particular, vancomycin-resistant enterococci (VRE) are one of the most challenging organisms in
clinical settings. Indeed, vancomycin-resistant Enterococcus faecium have been designated by the Infectious
Disease Society of America as one of the “superbugs” against which new therapies are urgently needed.
Daptomycin (DAP), a cell membrane-targeting lipopeptide antibiotic with potent in vitro bactericidal activity
against VRE, has become a key “front-line” antimicrobial agent against these organisms. However,
development of resistance during therapy is a daunting challenge. The major mediator of DAP resistance in
enterococci is a cluster of genes (designated liaFSR) that encode a three-component regulatory system
involved in orchestrating the cell envelope adaptive response to antibiotics and antimicrobial peptides.
LiaR is the response regulator (LuxR-type) of the system whose activity seems to be regulated by LiaF and
LiaS (histidine kinase). However, the specific regulatory role of LiaF in enterococci is unknown.
Additionally, we have identified a cluster of three genes that are mediators of the LiaR response (designated
liaXYZ). LiaX is a surface exposed and secreted protein that appears to be the main orchestrator of the LiaR-
mediated cell membrane response by negatively regulating the LiaFSR system, controlling cell membrane
phospholipid remodeling (a phenotype associated with DAP resistance). Additionally, the N-terminus of LiaX
interacts with penicillin-binding protein 5 (a key enterococcal enzyme required for cell-wall synthesis in the
presence of β-lactams) and is likely to mediate the “see-saw” effect (hypersusceptibility to β-lactams upon
developing of DAP resistance). LiaY and LiaZ are two transmembrane proteins that are regulated by LiaX.
Our data indicate that LiaYZ are required for DAP resistance and that LiaY is likely responsible for changes
in cell membrane phospholipid architecture. Thus, the overarching hypothesis of our proposal is that
understanding the mechanisms by which LiaFSR and LiaXYZ orchestrate the cell membrane response against
antibiotics would provide novel insights into the molecular mechanisms of antimicrobial peptide resistance and
bacterial adaptation that could be exploited with novel therapeutic interventions. We plan to develop our
experimental approach in three major specific aims. In Sp. Aim I, we will investigate of the role of LiaF, a
transmembrane protein that seems to play a major and distinct role in the activation of the response regulator
LiaR in enterococci. In Specific Aim II, we will focus on the characterization of LiaX as the master effector of
the cell envelope adaptive response. Specific Aim III will assess the role LiaYZ as mediators of DAP resistance
and cell membrane remodeling under the assumption that such effect is mediated through interactions with
cardiolipin synthase, a major phospholipid enzyme. We expect to provide evidence for a novel biochemical
paradigm to the cell envelope response to antibiotics and, potentially, new targets for drug development.

Public health relevance
PROJECT NARRATIVE – PUBLIC HEALTH RELEVANCE Antibiotic resistance is one of the most critical public-health threats of the 21st century, a situation highlighted by the UN, World Health Organization, US Congress, CDC, IDSA and the President’s Council of Science and Technology. Vancomycin-resistant enterococci (VRE) are one of the most important hospital-associated, multidrug-resistant organisms affecting critically ill patients and is considered a serious public health threat by the CDC. Treatment of VRE infections poses immense therapeutic dilemmas in clinical settings due to the lack of reliable antibiotic options, making these infections untreatable in certain scenarios. This proposal seeks to develop innovative strategies to preserve the utility of anti-enterococcal antibiotics based on the characteriza- tion of novel proteins that orchestrate the manner by which VRE adapt their cell envelopes to counteract the antibiotic effect.